Repeat and Consensus Proteins: Stability, Cooperativity, Function, & Design

Project Summary The formation of elaborate molecular structures is a halmark of biological systems, resulting in enzyme newtorks, regulatory complexes, membrane signaling and packaging systems, scaffolding networks, and . The instructuions for assembly are encoded within the molecules themselves. Understanding how to read these instructions is a major goal in modern biology and in modern medicine, where understanding may lead to rational manipulation of disease mechanisms. One relatively simple yet no less spectacular self-assembly process is the protein folding problem. Understanding the rules, rates, and mechanisms of protein folding would help interpret all aspects of biology, including diseaes states relating to protein misfolding and aggregation. One of the central features of protien folding is cooperativity. Single-domain proteins fold in all-or-none reactions. This remarkable coupling phenomenon is likely to be important for avoiding misfolded/partly folded states in biology, but it complicates experimental studies of the folding process, masking intermediates, processes, and routes along the way to the native state. The proposed research uses a series of linear symmetric repeat proteins that display all the features of globular proteins, but greatly reduce the complexity of the problem, and allow nearset-neighbor models to be applied to quantify the energetic coupling that underlies cooperativity. This internal symmetry also permits detailed kinetic mechanisms to be tested and parameterized, including parallel pathway nucleation and propagation steps. These modes of analysis will be applied alpha helix and beta sheet containing repeats to measure cooperativity and nucleation kinetic processes and determine their structural origins. Using a recently identified length-variable set of repeats, the size of the repeats and their interfaces with their neighbors will be correlated to cooperativity terms. Further, we will delineate the sequence features that modulate length in this group of proteins, and explore the structural and energetic features of high-ID prepeat protien sequences and their relation to consensus sequnces.

Public health relevance
Narrative The proposed research will determine how parts of proteins come together to form stable structures with biological activities. We will achieve this by using a novel class of proteins where we can snap units together like leggos (children's builiding blocks) and compare the structures, stabilities, and speeds with which they fold up. These results will help to explain how proteins avoid forming toxic, misfolded aggregates, and what has gone wrong when they do.